Defective PKA Signaling in Cushing's Syndrome

ABSTRACT
Cushing’s syndrome occurs when the adrenal glands release too much of the stress hormone cortisol. This
endocrine disorder is naturally caused by adrenal or pituitary tumors and afflicts women five times more
frequently than men. Chronic exposure to cortisol also increases blood glucose and elevates blood pressure.
This proposal investigates the molecular pathogenesis of adrenal Cushing’s syndrome. This disease is often an
outcome of defective cAMP signaling in the adrenal cortex. Advances in precision medicine have identified point
mutations and insertions in protein kinase A catalytic subunits (PKAc) as drivers of this disease. The most
prevalent mutant is PKAc-L205R, which is found in ~45% of Cushing’s patients. Other genetic lesions include
PKAc-W196R. Both disease-causing mutations reside within a region of the kinase domain that interfaces with
its regulatory subunits. This protein-protein interface is necessary for autoinhibition of kinase activity, but also
directs the subcellular targeting of PKA holoenzymes through association with A kinase anchoring proteins
(AKAPs). Our biochemical, cell-based, and clinical analyses infer that carrying a mutant allele of PKAc-L205R
or W196R is sufficient to displace the kinase from normal subcellular sites of action in Cushing’s patients. This
has led to a working hypothesis that losing spatiotemporal control of protein kinase A underlies adrenal Cushing’s
syndrome. Aim 1 will test if i) restoration of PKA anchoring amends cortisol release, ii) identify which AKAPs
coordinate cortisol biosynthesis and iii) considers an opposing premise that “substrate rewiring” of PKAc variants
or altered enzyme stability drives Cushing’s syndrome. At first glance, the PKAc-L205R and PKAc-W196R
mutants look virtually identical. Yet we have discovered that these are physiochemically distinct kinases that
engage different cell signaling pathways. Analyses of patient tissue reveal that PKAc-L205R mobilizes the Hippo
signaling pathway to control organ size. Conversely phenotypic profiling of adrenal-specific knock-in mice indicate
that PKAc-W196R activates the ERK mitogenic kinase cascade. Aim 2 will evaluate i) if female PKAcWT/W196R
mice are more prone to Cushing’s comorbidities, ii) test if PKAc-L205R engages the Hippo signaling cascade to
drive cortisol hyperproduction and iii) ascertain if PKAc-W196R coordinates ERK signaling events to promote
adrenal hyperplasia. This proposal explores two transformative ideas that will change how we think about
Cushing’s syndrome. 1) Losing spatiotemporal control of protein kinase A underlies adrenal Cushing’s
pathologies. 2) Adjacent and identical mutations in PKAc drive adrenal hyperplasia and cortisol hypersecretion
in Cushing’s patients.

Public health relevance
NARRATIVE Endocrine diseases have a substantial impact on public health. Cushing’s syndrome occurs when the body produces too much of the stress hormone cortisol. This is often a consequence of defective cAMP signaling in adrenal glands. We test two transformative ideas that change how we think about Cushing’s syndrome. 1) Losing spatial control of the enzyme protein kinase A (PKA) is a molecular event that drives adrenal Cushing’s syndrome and 2) related disease-causing mutations in PKA promote distinct pathological effects.